An Analysis of ICE R391 Pathogen-encoded Rum DNA Polymerase in Generating Mutations Driving Rapid Acquisition of Antibiotic Drug Resistance in Diverse Recipient Bacterial Species

PROJECT SUMMARY
The acquisition of resistance to antibiotics (Abs) in pathogenic bacteria has grown into a
worldwide pandemic, with around 3 million cases and roughly 35,000 deaths in 2019, according
to the CDC. Bacteria can acquire Ab resistance by the horizontal transfer of speciﬁc Ab resistance
genes, and by the de novo occurrence of mutations caused by exposure to Abs or to a wide
variety of naturally occurring external stressors, e.g., UV radiation, environmental pollutants. Our
grant proposal is centered on the acquisition of Ab resistance in bacteria caused by mutations
resulting from the transfer of a highly error-prone DNA polymerase, Rum pol, encoded by the
integrative conjugative element R391. R391 is found ubiquitously in nature. We have previously
shown that the pathogen-encoded Rum pol, in order to be enzymatically active in vitro and active
mutagenically in multiple types of recipient bacteria, must be assembled into a mutasomal
complex requiring the stable presence of each individual homolog RecA recombinase and ATP,
Rum Mut = Rum pol-RecA-ATP. This proposal will test our hypothesis that by generating a broad
mutational landscape, Rum pol is responsible for driving the rapid acquisition of Ab resistance in
its bacterial recipient cells. We further hypothesize that a single methionine at position 197 in
RecA (RecA M197), which is conserved in RecA recipient cell homologs, serves as a “master
regulator” for Rum pol mutagenesis and for the acquisition of Ab and multi-Ab resistance. Our
recent published data provide strong support for this hypothesis, and new preliminary data
strongly reinforce this hypothesis. We will use ICE R391 “donor” and Escherichia coli and Vibrio
cholerae recipient bacteria as our model system. There are two in vivo microbiology and two
mechanistic based speciﬁc aims. Aim 1 investigates the role of Rum pol in rapid acquisition of Ab
resistance; Aim 2 maps regions of Ab- and external stressor-induced genomic instability (ssDNA)
globally in genomic DNA, maps the location of Rum pol on the genome, and identiﬁes the all of
the mutations using NG sequencing; Aim 3 visualizes the assembly Rum pol into Rum Mut at
single molecule resolution in real-time using TIRF-FRET microscopy; Aim 4 will obtain high-
resolution structures of Activated Rum Mut using Cryo-electron microscopy. An important
objective is to identify speciﬁc sites in Rum Mut that can serve as targets for the design and
discovery of small molecule inhibitors that prevent assembly of Rum pol into mutagenically active
Rum Mut or that inhibit the activity of activated Rum Mut.

Public health relevance
PROJECT NARRATIVE The occurrence of drug-resistant pathogenic bacteria is a rapidly expanding world-wide pandemic emanating principally from the over-abundant prescription of antibiotics to treat human infections and their use as additives in animal feed. We have identiﬁed a speciﬁc enzyme, a DNA polymerase that copies bacterial DNA in a hugely error-prone manner, which is produced by a highly mobile genetic element that is transferred to a wide range of potentially pathogenic recipient bacteria that infect humans. Our studies are intended to test our idea that this speciﬁc pathogen- produced DNA polymerase is responsible for generating a wide range of mutations that cause a rapid acceleration of antibiotic resistance in bacteria, and to develop strategies to disable the polymerase to greatly retard the development of drug resistance in natural and hospital environments.